Indiana University Comprehensive Training in Clinical Pharmacology

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
There is a critical need of well-trained clinical scientist that can augment the translation of new therapies into clinical practice and to ensure the safe and effective use of medications. The Indiana University Comprehensive Training Program in Clinical Pharmacology (T32GM008425), currently in the 29th year and trained over 50 scientists in clinical pharmacology, seeks to continue preparing fellows (MDs, PharmDs, PharmD/PhDs, DNPs, MD/PhDs, PhDs or equivalent) for careers in translational and clinical therapeutics. Fellows have access to 40 committed, vibrant, and multidisciplinary participating faculty drawn from a broad range of basic and clinical therapeutics research programs (25 preceptors selected based on research quality, peer-reviewed funding, collaborative relationships, and mentoring commitment, and 15 participating in other roles). Trainees conduct research (laboratory, clinical and/or in silico) under the mentorship of one of the preceptors. Collaborations among the preceptors include pharmacogenomics, adverse drug reactions, drug-drug interactions, drug disposition, drug discovery and development, quantitative pharmacology, pediatric pharmacology, precision medicine, biomarker of drug response and therapeutic outcomes. Trainees will also receive formal training in broad clinical pharmacology issues and skills and in research ethics and responsible conduct of research to prepare trainees for the complexities involved in the research and practice of translational therapeutics. Fellows attend team journal clubs specifically organized to break down silos twice monthly, seminars in clinical pharmacology and personalized medicine every week, and an organized didactic program every week. The didactic training concentrates on PK/PD, drug and metabolite analysis, pharmacogenomics, quantitative pharmacology, biostatistics, clinical trial design, drug discovery and development, research ethics and the responsible conduct of research. The training occurs in an exceptionally rich, synergetic, and complementary training environment. The institutional support to strengthen the Division and its training program is outstanding. The training program continues to generate clinical pharmacologists who have assumed prominent roles in academia, the pharmaceutical industry, and regulatory agencies. Qualified applicants have always filled the training grant slots. In fact, we receive substantially more qualified applicants than available positions. Our program is accredited by the American Board of Clinical Pharmacology. Because the Division of Clinical Pharmacology at Indiana University has a long and distinguished record of excellence in training leaders in clinical pharmacology and translational therapeutics and our training program currently represents one of the strongest, most comprehensive, and cutting-edge training, we are in a unique position to successfully continue training outstanding future leaders in the discipline.

Public health relevance
The Indiana University (IU) Comprehensive Training Program in Clinical Pharmacology, currently in its 29th year, has a track record of excellence in training successful clinician scientists able to implement the science of clinical pharmacology and therapeutics in academic, pharmaceutical industry/biotechnology and drug regulatory agencies. We propose to continue this successful training program in a setting of a well-established Division of Clinical Pharmacology, multiple well-funded and experienced investigators to mentor trainees, a pipeline of highly qualified applicants, and outstanding institutional training environment and support. Our goal is to continue generating clinical scientists that can augment translation of new therapies into clinical practice and ensure safe and beneficial effects of medications.